Brain and behavioral alterations in a nonhuman primate model of maternal immune activation: mPFC-amygdala circuitry, neuroinflammation, and socioemotional development

PROPOSAL SUMMARY
Exposure to viral or bacterial infections during pregnancy increases risk for offspring
neurodevelopmental disorders, including autism and schizophrenia. Gestational biomarkers indicate that the
maternal immune response plays a critical role in altered fetal neurodevelopment. Our ability to mitigate the
harmful effects of maternal immune activation (MIA) on offspring neurodevelopment is limited by our
incomplete mechanistic understanding of the neurobiological changes associated with prenatal exposure to
MIA. While rodent studies have shown similarities between alterations in brain and behavioral development in
MIA-exposed offspring and changes observed in human neurodevelopmental disorders, there are limitations in
translating these findings to human neuroanatomy and physiology. It is therefore necessary to expand this
research to a preclinical model more closely related to humans, such as nonhuman primates (NHPs).
My primary mentor’s laboratory (Bauman) has developed the first viral-mimic based rhesus macaque
model of MIA exposure in pregnancy. For this K01 Career Development Award, I propose to leverage the
entirety of biobehavioral data available for the NHP MIA model to examine the effects of neuroimmune
changes on behavioral and brain alterations in MIA-exposed NHPs. My outstanding mentorship team will
provide foundational training in immunology (Van de Water) and the use of NHP models (Bauman) to
accelerate complex translational biomedical research in neurodevelopmental disorders (Schumann). This
award, which represents a critical next step in my development as an independent research scientist, provides
an opportunity to make use of my unique skill set in human and NHP cellular and molecular neuroanatomy,
while expanding the breadth of my research foci in the unique institutional environment provided by UC Davis
and the California National Primate Research Center.
Our research will contribute to our understanding of the behavioral and neurobiological changes
associated with prenatal exposure to MIA. Specifically, we will apply novel behavioral phenotyping paradigms
to evaluate alterations in socioemotional behavior in the MIA-exposed NHP (Aim 1a). We will longitudinally
map the development of the amygdala in MIA-exposed NHPs and controls to understand the course of MIA-
induced structural brain changes (Aim 1b). Using postmortem tissue collected from subjects at two critical age
time points, we will examine neuroimmune proteomic alterations in the amygdala and medial prefrontal cortex
(Aim 2a). Using markers for neuroimmune targets identified in Aim 2a, we will map the expression of
neuroimmune transcripts in specific cell types in brain tissue sections (Aim 2b). Together, these data build a
comprehensive picture of MIA-induced changes in NHP brain circuitry, toward the ultimate goal of identifying
pathways of vulnerability and critical periods for novel, targeted interventions and biotherapeutics.

Public health relevance
NARRATIVE Maternal infection during pregnancy is a known risk factor for offspring neurodevelopmental disorders, including autism and schizophrenia. Here, we use a nonhuman primate model of maternal immune activation in pregnancy to study changes in offspring behavior and brain structure, as well as postmortem changes in cellular and molecular organization. The goal of this research is to identify pathways and critical periods for the development of targeted interventions and therapeutics to improve mental health outcomes for individuals at- risk for severe neurodevelopmental disorders.